Defining the Role of Immunoglobulin G4 (IgG4) in Food-Induced Eosinophilic Esophagitis (EoE)

PROJECT SUMMARY/ABSTRACT
Over the past two decades, eosinophilic esophagitis (EoE) has transformed from a case-reportable disease to
a major cause of upper gastrointestinal morbidity. EoE is primarily triggered by food, as diets eliminating
common food allergens can lead to long-term disease remission. However, accurate tests to identify food
triggers in individual patients do not yet exist because we do not fully understand the mechanisms of this food-
induced inflammation. We now know that this inflammation is not mediated by IgE, and diets based on IgE to
foods have had limited success. In contrast, another immunoglobulin — IgG4 — is produced locally in the
esophagus of EoE patients, and tissue levels of IgG4 correlate with disease activity. Using
immunofluorescence (IF), we have generated preliminary data that IgG4 and food proteins co-localize in the
esophageal tissue of EoE patients with active disease, which is suggestive of immune complex formation. We
have further found that these IgG4-food deposits are located in close proximity to proteins associated with
eosinophil activation, antigen presentation, and T cells. Defining a role for IgG4 in the pathogenesis of EoE
could fundamentally change our understanding of this condition — and of IgG4 — and could facilitate
the development of novel diagnostic tests and therapies for this disease.
Our overall hypothesis is that IgG4 contributes to food-induced inflammation in EoE. In Aim 1, we will
determine whether IgG4 forms immune complexes with food, which then promote high-avidity interactions to
activate eosinophils in the esophageal tissue of patients with food-induced EoE. In Aim 2, we will establish
whether dendritic cell activation by IgG4-bound antigen amplifies the underlying T cell immune response in
EoE. This will be assessed using 1) a validated milk challenge study where esophageal biopsies will be
collected from EoE patients in remission on diet and after milk reintroduction and 2) in vitro stimulation assays
using novel milk-specific IgG4 monoclonal antibodies (mAbs) generated from patients with EoE.
Our group is uniquely positioned to address this critical knowledge gap because of our access to large EoE
populations, our expertise in novel spatial and T cell phenotyping techniques, and our ability to generate IgG4
mAbs for in vitro assays. We expect to find that IgG4 contributes to food-induced inflammation in EoE.
Regardless of the outcomes, these results will provide novel insights into the mechanisms of food-induced
inflammation in EoE and may fundamentally change our understanding of the pathogenesis of this disease.

Public health relevance
PROJECT NARRATIVE While eosinophilic esophagitis (EoE) is known to be primarily triggered by food antigens, the mechanisms underlying this food-induced inflammation remain unknown. We expect to demonstrate that IgG4 forms immune complexes with food and stimulates local immune cells in EoE, thereby contributing to food-induced inflammation in this disease. Characterizing the role of IgG4 in EoE could lead to a paradigm shift in our understanding of this condition, as well as novel diagnostic and treatment approaches.